GENETIC DETERMINANTS OF OSTEOPOROSIS SUSCEPTIBILITY

Families of Ashkenazi Jewish decent are enrolled into this study with osteoporotic postmenopausal women as the proband. Phenotype and genotype data is collected on family members and entered into a data base. Analysis will be performed when all data is collected.